Patient-Centered Outcomes of the First Approved Peanut Allergy Treatment

PROJECT SUMMARY/ABSTRACT
Jennifer Dantzer, MD MHS is an allergy and immunology physician-scientist at Johns Hopkins University, with
a Master's Degree in Epidemiology. This K23 award will provide her valuable training towards her long-term
career goal of being an independent investigator focused on patient centered outcomes (PCO) of food allergy
treatments. Food allergy is a major public health disorder that affects at least 5.9 million American children and
is increasing in prevalence. Historically, food allergy management has been based on strict allergen avoidance
and recognition and treatment of allergic reactions. However, the burden of food avoidance and on-going
uncertainty over possible accidental exposures can have a significant psychosocial impact on children and
parents. The FDA approved the first treatment for peanut allergy, Palforzia, peanut oral immunotherapy
(POIT), in January 2020, ushering in a new era for food allergy treatment. While this paradigm shift in food
allergy management is monumental, there is significant uncertainty related to benefits/risks to the patient,
treatment preferences, and patient-centered outcomes (PCO). This gap in our understanding lead to this
project's overall objective to evaluate the patient perceived benefit of peanut allergy therapy and to better
understand decision-making with regard to discontinuation and treatment preferences. Aim 1 will examine
longitudinal change in child, adolescent, and caregiver food allergy related quality of life in a diverse, real-world
population on and off POIT. In addition, the long-term benefit of POIT is dependent upon on-going treatment
since stopping treatment causes the majority of patients to lose most or all protection. Aim 2 will use local and
national data as well as interviews and questionnaires to determine the rates, potential predictors, and reasons
for POIT discontinuation. Finally, Aim 3 will use a mixed methods approach to understand patient and parent
preferences for PA treatment. This K23 award addresses the mission of NIAID to better understand and treat
allergic diseases by using a novel approach and methods directed towards PCO research. The research will
be completed within the highly supportive training environment at Johns Hopkins, with the guidance of a team
of expert mentors with relevant expertise (Drs. Robert Wood, MD, Corinne Keet, MD PhD, Albert Wu, MD
MPH, Cynthia Rand, PhD and John F.P. Bridges, PhD). The career development plan combines hands-on
training, formal didactics, and outstanding mentorship in key areas of statistical analysis, epidemiology, and
advanced techniques in PCO research. This plan will ensure a successful transition to independence. This
K23 award will provide preliminary data and skills that are highly relevant and applicable to future R01 or U
level grants. Findings have the potential to change clinical practice not only related to POIT, but also for future
food allergy treatments, through enhanced benefit-risk assessment, best practice guidelines, and patient
decision-making tools.

Public health relevance
PROJECT NARRATIVE Peanut allergy is a growing public health concern that can lead to severe anaphylaxis and significant psychological burden. We are entering a new era of food allergy management sparked by the recent approval of the first drug for peanut allergy with many additional therapeutics in clinical trials, but the influence of these treatments on a patient's life is unknown. The goal of the proposed research is to evaluate the patient perceived benefit of PA therapy and to better understand patient decision-making with regard to discontinuation and treatment preferences.